Developmental Core

THE HARC CENTER: HIV ACCESSORY AND REGULATORY COMPLEXES
DEVELOPMENTAL CORE
SUMMARY
The mission of the HARC Center Developmental Core is to stimulate HIV research, foster internal and external
collaborations, and support Center investigators and members - with an emphasis on early-career researchers
- in their career trajectories and development. We aim to build a strong and diverse community of researchers
using structural and systems biology techniques to advance the knowledge of HIV prevention, treatment, and
cure.
The Developmental Core will support the Center’s postdoctoral fellows and junior faculty without independent
research support through the Mentored Scientist Awards, which not only provide guidance to the awardees from
senior faculty, but also enables them to gain hands-on experience in mentoring summer intern students who are
recruited by the Developmental Core in partnership with existing internship programs supporting
underrepresented minorities in the sciences. Additionally, the Developmental Core will provide a broad portfolio
of training and career development opportunities for HIV systems biology researchers. To foster innovation
through collaboration, and expand and strengthen the community of HIV structural and systems biology
researchers, the Developmental Core will implement and oversee the Collaborative Development Award (CDA)
Program. This program will provide early-career investigators in the HIV/AIDS field as well as investigators who
are new to HIV research from outside the HARC Center the opportunity to enhance the Center’s overall research
theme through the short- term exploration of highly innovative or high-risk concepts.